Virology Core

The overall goal of the Virology Core Laboratory is to enhance HIV and AIDS research at Baylor College of Medicine and UTHouston by providing comprehensive state-of-the-art virological assays and services. The Virology Core Laboratory will also make available its specialized BSL2/3 laboratory facilities to CFAR AIDS researchers and train these researchers in the proper usage of the facilities. The Core is headed by Dr. Andrew P. Rice, who has over 16 years'experience as a molecular virologist working on HIV. Dr. Edward Siwak, Associate Core Director, an experienced manager, is responsible for the day-to-day supervision of the Core. The Core also includes an experienced staff with specific expertise in the assays performed by the Core. A major goal of the Core is to exploit its expertise to facilitate collaborative research initiatives with other Core Laboratories and investigators of the Baylor-UTHouston CFAR. Current major Virology Core services include: (1) assays of HIV-1 infectivity by means of quantitative microcultures;(2) PCR-based assays for HIV-1 RNA and DNA and cellular mRNAs;(3) p24 antigen assays;(4) processing, storage and shipment of specimens and other biological samples from patients with HIV infection;and (5) training and usage of BSL2/3 facilities. Finally, the Virology Core has a program in place to evaluate annually the current and future needs of CFAR investigators and provide them with new assays and services as needed for clinical, basic, and translational research projects.